Evaluation of the neuroimmune mechanisms influencing therapeutic targetingpotential of the LH/CG receptor in the menopausal and AD brain

PROJECT SUMMARY
Menopause is midlife event that promotes adverse outcomes in the female brain. The systemic
proinflammatory state induced by large fluctuations and changes in ovarian and pituitary hormones is thought to
exacerbate peripheral and centrally mediated neuroinflammation that increase the risk of AD in women
compared to men. Our previous work has demonstrated that the gonadotropin LH/CG receptor-ligand complex
is as a therapeutically relevant nexus for menopausal and AD-related cognitive and neuroplasticity loss. We
have now identified that these benefits may be facilitated through immune regulating properties; known for this
receptor complex in the periphery but completely unexplored in the CNS. We have identified that LH/CG receptor
activation using hCG is particularly effective at normalizing myeloid cell peripheral infiltration exacerbated by
ovariectomy (to model menopause) in the rodent AD model brain. This proinflammatory mechanism is regarded
as a key driver of AD pathogenesis, underscoring the significance of evaluating this hormone-receptor complex
in this context. A potential immune-regulating role for the LHCGR in the CNS are bolstered by its expression in
microglia and excitatory neurons, both key mediators of neuroinflammation in disease states. Therefore, here
we seek to address if this hormone-receptor complex yields CNS benefits through regulation of
neuroinflammatory mechanisms that are relevant in AD development. Specifically, AIM 1 will evaluate the cell
specific role of the LHCGR signaling on CNS function, neuroplasticity, and inflammatory processes through
conditional deletion. AIM 2 will address whether the functional and neuroplasticity benefits associated with
stimulating this receptor complex involve the inhibition of peripheral infiltration mechanisms; also, how this
proinflammatory mechanism and therapeutic benefits are impacted by age, reproductive status, and amyloidosis.
AIM 3 will determine how age and reproductive status specific baseline levels of centrally produced ligand (LH),
receptor expression levels, and/or its cellular localization influence the therapeutic outcomes of this receptor’s
target engagement. This work will advance our understanding of this understudied receptor complex in the brain
and its relation to incrased risk of AD development in women. More broadly, it will expand our knowledge base
on neuroendocrine regulation of important disease driving neuroinflammatory processes. Notably, given the
involvement of peripheral immune cell infiltration-based inflammatory processes, in several neurological
conditions (TBI, neurogenerative disorders, stroke, epilepsy, severe infection) the mechanistic evaluation of
LHCGR signaling in this context can inform therapy beyond AD risk factors.

Public health relevance
PROJECT NARRATIVE Hormones are powerful immune regulators and their dysregulation during aging can have profound impact on pro-inflammatory events that negatively affect the CNS and influence the onset of Alzheimer’s disease. We have identified that the LH/CG receptor has powerful neuroimmune regulating capabilities linked to peripheral immune cell infiltration, a pathogenic mechanism associated with aging, accelerated by menopause, and linked to cognitive impairment and increased dementia risk. Based on this, we seek to elucidate the neuroimmune modulating mechanisms of LHCGR signaling that may explain the observed therapeutic benefits of modulating this hormone-receptor complex in the menopausal and AD brain.